2025 Tropical Infectious Diseases Gordon Research Conference and Seminar

Summary
The 2025 Gordon Research Conference on Tropical Infectious Diseases (2025 GRC-TID) and its preceding
event, the 2025 Gordon Research Seminars on Tropical Infectious Diseases (2025 GRS-TID), are renowned for
fostering innovation and collaboration in global health and infectious diseases. The conference seeks to promote
inclusivity and diversity in participation, aiming to narrow the divide between high-income and low-income
nations. Despite affecting over a billion individuals in 149 countries, neglected tropical infectious diseases have
historically been overlooked in attention and funding, creating significant obstacles in research and intervention
efforts. The conference’s Specific Aims 1. Enhance diversity in the community. To enhance diversity by
promoting gender equity and geographic representation, with equal gender distribution among speakers.
Financial support is provided for attendees from underrepresented backgrounds. The venue for the event has
been moved from the USA to Italy to improve accessibility. It also provides accommodations for individuals with
disabilities.
Specific Aims 2. To overcome critical challenges hindering progress. The program covers various topics,
including vaccine development, host-pathogen interactions, global health challenges, and more. It challenges
current paradigms by covering all groups of tropical pathogens (bacteria, fungi, parasites, and viruses) and
vectors, fostering interdisciplinary collaboration for innovative disease prevention strategies. 2025 GRC-ITD
focuses on the latest research, diagnostic and treatment advances and disease control measures. Specific
Aims 3. Foster career development. The conference prioritizes career development through mentorship
opportunities for scientists at all career stages. Participants can expand their expertise and forge lasting
connections by fostering networking and informal exchanges. The expected impact of the 2025 GRC-TID and
GRC-IDT is to advance scientific knowledge, drive innovation, and promote collaboration in the fight against
infectious diseases. The conference aims to spark transformative breakthroughs in disease management and
control strategies by championing inclusivity and diversity.
In conclusion, the 2025 GRC-TID continues its legacy of excellence in scientific research and collaboration,
shaping a brighter future for global health and tropical infectious diseases. The 2025 GRC-TID is significant in
bringing together global researchers to address the challenges of tropical infectious diseases that
disproportionately impact vulnerable populations.

Public health relevance
Project Narrative The 2025 Gordon Research Conference and Seminar on Tropical Infectious Diseases is an important international event focusing on global health innovation and collaboration. The conference promotes diversity and inclusivity among participants, covering all major tropical pathogens and emphasizing the development of vaccines, diagnostics, and treatments. It is instrumental in advancing scientific knowledge, encouraging diverse perspectives in research, and fostering professional growth, thereby contributing significantly to the global effort to manage and control tropical infectious diseases.